Recovering Together: Building resiliency in dyads of patients with an acute brain injury admitted to the Neuroscience Intensive Care Unit and their informal caregivers

PROJECT SUMMARY
Admission to the Neuroscience Intensive Care Unit (NICU) for an acute neurological illness (ANI; e.g., stroke, tumor, TBI)
is often sudden and traumatic. Approximately 20-40% of survivors and their caregivers endorse clinically significant
emotional distress and posttraumatic stress symptoms (PTS) at hospitalization, which tend to become chronic and negatively
impact the recovery trajectory and overall quality of life. Unfortunately, there are no efficacious interventions to prevent
chronic emotional distress in these patients and caregivers. With funding from NINR, our multidisciplinary team recently
conducted a pilot study examining the delivery of a brief, 6-session ( 2 in person, 4 via live video) dyadic resiliency
intervention (Recovering Together) to prevent chronic emotional distress in at risk survivors and caregivers. In a single
blind RCT of Recovering Together versus a time, dose and attention matched educational control, we met a priori set
markers of feasibility, acceptability, credibility and adherence. We also observed statistically and clinically significant
effects of the active intervention on reduction in symptoms of emotional distress and PTS. Findings have been published in
JAMA Network. For the proposed project, we seek to build on our prior positive findings by conducting a fully powered,
efficacy, single blind randomized controlled trial (RCT) of the intervention in a larger sample of dyads of patients with ANI
and their caregivers. The goals of this study are to:1) demonstrate the efficacy of Recovering Together for improving self-
reported dyadic emotional distress (primary outcome), and PTS, mindfulness, coping, and interpersonal interaction variables
(secondary outcomes); and 2) assess mechanisms (mediators and moderators) of improvement after intervention. We will
enroll and randomly assign 194 at risk dyads (97 per study group) to receive either Recovering Together or the attention
placebo educational control. The trial will take place at the Massachusetts General Hospital NICU using our established
methodology successfully implemented during the R21. Study clinicians will deliver 6, 30 minute sessions (2 at bedside
and 4 via live video after discharge) to each patient-caregiver dyad. All participants will complete measures at baseline,
after completion of program (6 weeks) and 3 months later. Data from this R01 will ultimately serve as the basis to apply for
funding for a large-scale, multisite hybrid effectiveness-implementation study followed by scalability of Recovering
Together to other NICUs from across USA.

Public health relevance
PROJECT NARRATIVE Approximately 20-40% of patients with acute neurological illness hospitalized in a Neuroscience Intensive Care Unit (NICU) and their informal caregivers experience clinically significant emotional distress which becomes chronic, and is associated with worse recovery trajectory and overall quality of life. The purpose of the present investigation is to test the efficacy of a brief (6 sessions) dyadic (patient and caregiver together) intervention to prevent chronic emotional distress. Through this study, we seek to solve the unmet need of preventing chronic emotional distress in NICU dyads through a feasible, acceptable and credible program, and ideally improve the recovery trajectory and dyads' overall quality of life.